Novel ultra-short cell free DNA biomarkers for early detection of non-small cell lung cancer.

PROJECT SUMMARY/ABSTRACT
Lung cancer remains the leading cause of cancer-related deaths in the U.S. and worldwide. Non–small cell
lung cancer (NSCLC) accounts for approximately 85% of all lung cancers. Early detection of indeterminate
pulmonary nodules (IPNs) with chest low dose computed tomography (LDCT) screening followed by effective
treatments can reduce mortality by 20% relative to chest radiography. However, the high false positive rate
finding as >95% limits the application. The unmet clinical need for early diagnosis is the lack of a noninvasive
test that can be applied to individuals with CT-detected lung nodules and reliably discriminates between
malignant or benign nodules. Liquid biopsy focused on the characterization of tumor-associated genetic
alterations in cell free circulating tumor DNA can non-invasively profile the molecular landscape of solid tumors.
However, the low biological concentrations of ctDNA, low frequency of somatic mutations and the confounding
impact of clonal hematopoiesis-related variants in early-stage lung cancer limit the sensitivity of ctDNA-based
liquid biopsy assays. It would be essential if additional cell free DNA biomarkers could be included to allow the
development of more sensitive molecular diagnostics approaches for the early assessment of lung cancer.
We have discovered a distinct population of ultra-short single-stranded cell-free DNA (uscf/ctDNA) with a
size of 40-70nt in healthy and NSCLC plasma. Our preliminary data showed that the fragmentomic features,
including functional element profile, fragmentation patterns and end motifs of uscfDNA molecules, can
distinguish NSCLC patients from healthy donors. This R21 application is to explore and test our hypothesis that
the fragmentomic features of uscfDNA molecules can serve as novel biomarkers to differentiate NSCLC patients
from non-cancer subjects with IPNs and allow more sensitive liquid biopsy molecular diagnostics for early
NSCLC detection. Two specific aims are in place for hypothesis testing. Aim 1 is to develop a predictive model
using uscfDNA-seq assay on uscfDNA fragmentomic analysis for liquid biopsy of NSCLC. Aim 2 is to pre-validate
uscfDNA-Seq test for the early detection of NSCLC. Together, the translational and pre-validation, targeting
uscfDNA for early detection of NSCLC can break new ground and extend previous discoveries towards impactful
new directions and clinical applications.

Public health relevance
PROJECT NARRATIVE Lung cancer is the leading cause of cancer death in the U.S. and worldwide. This application seeks to develop novel blood-based lung cancer-associated molecular markers to distinguish between patients with benign or malignant nodules detected on computed tomography. It can provide a ground-breaking improvement in sensitivity and specificity as required to reliably detect lung cancer at an early stage.